Piezoelectric bioscaffold for the treatment of volumetric muscle loss

Project summary/Abstract
Skeletal muscle has a remarkable regenerative capability when the extent of the injury is relatively minor.
However, following traumatic muscle injuries such as volumetric muscle loss (VML), the endogenous repair
potential of skeletal muscle becomes inadequate, which causes physical disability and adversely influences the
quality of life. Biomaterial scaffolds hold great promise for improving the functional recovery of skeletal muscle
by providing both physical and biochemical cues to facilitate cell adhesion, migration, proliferation, and
differentiation. Particularly, acellular scaffolds are promising and clinically transformative as they obviate
limitations associated with using exogenous cells, including limited sources and immunogenicity. However,
existing acellular bioscaffolds have failed to induce the formation of a sufficient amount of de novo myofibers
and achieve appreciable muscle functional improvement, limitations that have been largely attributed to the poor
ability of acellular scaffolds to recruit endogenous cells, especially muscle stem cells (MuSCs). Therefore,
developing an acellular scaffold capable of active cell recruitment represents a major technological advance in
the treatment of VML. Inspired by the native tissues such as skin that generate electrical signals to guide cell
migration during injury repair, we propose to develop a biodegradable piezoelectric scaffold comprised of a fibrin-
based hydrogel containing boron nitride nanotubes (fibrin/BNNTs). Our scaffold is designed to convert
mechanical stimuli (e.g., via ultrasound and exercise-induced muscle contraction) to electrical signals with the
goal of promoting cell recruitment. In this proposal, we will test our central hypothesis that, upon ultrasound
stimulation, fibrin/BNNTs piezoelectric scaffolds enhance endogenous cell recruitment and MuSC differentiation,
thus accelerating the functional recovery of skeletal muscle after VML. Two specific aims are proposed to test
our central hypothesis. Specific Aim 1 studies will optimize the fibrin/BNNTs scaffold composition and ultrasound
stimulation to promote MuSC recruitment and myogenic differentiation in vitro using a novel 3D VML muscle
construct model. In Specific Aim 2, using our validated VML male and female mouse models, we will evaluate
the ability of ultrasound-stimulated piezoelectric scaffolds to promote in vivo skeletal muscle regeneration, and
we will evaluate whether these effects are sex-dependent. We anticipate that the successful completion of these
studies will not only offer a promising new strategy for enhancing skeletal muscle regeneration but also provide
novel insights into scaffold design for other applications, such as skin and cardiac regeneration.

Public health relevance
Narrative Severe muscle injury such as volumetric muscle loss (VML) can greatly compromise physical function and quality of life. This project aims to develop a novel piezoelectric scaffold that can actively recruit endogenous muscle cells by generating electrical signals upon ultrasound stimulation. Both in vitro and in vivo studies have been designed to evaluate the ability of ultrasound-stimulated piezoelectric scaffolds to restore muscle function following VML injuries and to provide insights into future bioactive tissue scaffold design.